Cognitive Rehabilitation for Older Veterans with Mild Cognitive Impairment

Due to the aging of the United States population, age-related cognitive problems resulting from Alzheimer’s
disease and other causes of dementia are increasingly prevalent. Before individuals are diagnosed with
dementia, they typically exhibit a period of “mild cognitive impairment” (MCI). Mild cognitive problems
associated with MCI frequently impact an individual’s ability to perform everyday tasks, including working,
independent living, and medication adherence. Veterans are at increased risk of cognitive decline, and the
Veterans Healthcare Administration (VA) is now providing health care to surging numbers of older Veterans
with MCI who report significant cognitive complaints, difficulties with everyday functioning, and concerns about
impending dementia. Despite high patient demand, few cognitive rehabilitation interventions exist that
specifically address the needs of older Veterans with MCI that are widely accessible, patient-centered, and
evidence-based. To our knowledge, no randomized controlled trials have been conducted that evaluate the
efficacy of manualized, brief and inexpensive, yet comprehensive (multi-modal) cognitive rehabilitation
interventions for older Veterans with MCI. Hence, the primary objective of this study is to evaluate the efficacy
of Motivationally Enhanced Compensatory Cognitive Training (ME-CCT), a manualized cognitive rehabilitation
group treatment for older Veterans with MCI. The study’s specific aims are to determine whether ME-CCT is
effective for: 1) improving objective cognitive performance and functional capacity, 2) improving subjective
cognitive complaints, subjective functioning, and collateral measures of everyday function, and 3) increasing
modifiable protective factors (e.g., diet, exercise) associated with reduced risk for MCI. We will also explore
mediators and moderators of treatment effects. The overall goal is to evaluate a manualized group treatment
for the symptoms of MCI that can be readily implemented in VA treatment settings. The study design makes
use of the convergent availability of resources at the two participating VA Healthcare Systems in San Diego,
California and Portland, Oregon to conduct a randomized controlled trial of ME-CCT. The study will recruit a
sample of 216 Veterans (108 at each site) who meet criteria for MCI. Inclusion criteria will be: 1) Veterans 55
years old or older enrolled at one of the participating VAs who are able to provide informed consent, 2)
Independently living, 3) Meet criteria for MCI based on previously published criteria (Petersen, 2004; Petersen,
2011), and 4) Willingness to participate in audio-recorded group sessions. Exclusion criteria will be: 1) Current
substance use disorder with less than 30 days abstinence, 2) History of schizophrenia, schizoaffective
disorder, or other primary psychotic disorder, 3) History of significant head trauma with loss of consciousness
>30 minutes, and 4) Auditory or visual impairments that would prevent ability to participate in the cognitive
rehabilitation group. Eligible participants will be randomly assigned to either the ME-CCT or an active control
group, Goal-focused Supportive Contact (SC). The SC group will provide the same frequency and amount of
therapist and peer contact as ME-CCT, but without specific training in cognitive strategies, lifestyle strategies,
or motivational enhancement. 10 2-hour long weekly sessions will be delivered in both conditions. Both groups
will undergo evaluations at baseline, 5 weeks (midway through the intervention), 10 weeks (immediately
following the end of the intervention), and 23 weeks (3 months after completion of the intervention).

Public health relevance
The number of older Veterans with Mild Cognitive Impairment (MCI) seeking care within the Veterans Affairs (VA) health care system is increasing and is expected to increase more rapidly as Vietnam era Veterans age. The cognitive effects of MCI and subsequent neurodegenerative disorders can adversely affect a Veteran’s ability to function independently and failure to provide appropriate intervention can result in an increased need for healthcare services and VA benefits in the future. The VA currently spends over $19,000 annually per patient to care for Veterans with dementia (Zhu et al., 2009), and delaying the onset of dementia even by one to two years will result in substantial financial savings to the VA and quality of life gains for the Veteran. Since present pharmacological interventions have demonstrated limited efficacy, alternative treatments are needed. Therefore, an evidence-based cognitive training intervention that optimally addresses the needs of older Veterans with MCI is of critical importance to the VA patient care mission.